Image Features for Brain Phenotypes

Project Summary/Abstract TR&D 3 Image Features for Brain Phenotypes
Modern brain imaging provides vastly more information than before. While this information is of tremendous
benefit to patients, the radiologist’s workload has increased with higher resolutions and increasing numbers of
images to interpret. Furthermore, rare brain malformations, rare diseases, and brain abnormalities that are
diffusely manifested or are symmetric across hemispheres can pose particular challenges to the radiologist.
Despite the rich information content of hospital image archives, there is no clinically available way to
automatically leverage the large volume of prior cases at the same hospital to aid radiological reads.
Toward the long-term goal of developing machine learning systems for clinically assisted reads, the Image
Features for Brain Phenotypes TR&D will investigate 3D brain image features for description of healthy versus
non-healthy brain phenotypes. Image features are representations of image contents that have the following
advantages: they are compact, informative, facilitate fast search, and enable machine learning analyses of
large datasets. Even in an era of massively parallel computers, these advantages enable clinical problem
solving that would otherwise be infeasible in practice due to problem size and complexity.
We hypothesize that similarity in image features is strongly correlated with similarity in underlying disease, and
that this can be used to build novel tools to support radiological decisions. The project is organized into three
specific aims: (1) Robust image features for brain phenotypes that will develop features and associated
algorithms for 3D structural images, (2) Connectivity-based brain phenotypes that will investigate novel
features for diffusion MRI images, and (3) Feature-based brain phenotypes for the clinic that will deploy and
validate methods in clinical MRI databases. We will focus on the specific application of radiological images of
children 4 to 18 years old and we will leverage three large clinical MRI databases from Boston hospitals.
Overall, our proposed feature-based image analysis technologies have the potential to identify image
phenotypes describing particular malformations for clinically aided reads or radiological teaching, to identify
similar cases to aid patient counseling, and to enable detection of population substructure in disease. Our team
has significant successful experience in extracting valuable knowledge from clinically acquired data sources
and in disseminating open software for such research. The expected outcome of the proposed project is a
state-of-the-art open source pilot system for clinically aided reads.